Building an Integrated Laboratory System to Advance the Safety of Human and Animal Food

Project Summary/Abstract
The purpose of this proposal from the Association of Public Health Laboratories (APHL)
is to support and enhance the capabilities of state human and animal food (HAF) testing
laboratories that engage in surveillance and response activities associated with
foodborne hazards, including foodborne outbreak investigations.
APHL will:
• Build a competent HAF Laboratory workforce by developing and delivering
trainings, workshops, seminars and other educational materials, and a
bioinformatics fellowship
• Integrate the HAF Laboratory system by planning and hosting high quality
conferences and meetings related to the LFFM disciplines, the GenomeTrakr
network, and NARMS
• Manage support programs for ISO/IEC 17025:2017 accreditation by providing
direct technical assistance to FERN laboratories and to non-FDA funded HAF
laboratories
• Support Laboratory Information Management System and ORA Data Exchange
implementation
• Enhance and maximize HAF laboratory participation in the GenomeTrakr network
and the Partnership for Food Protection IT Workgroup and Laboratory Science
Workgroup
• Promote information sharing between strategic partners, improve quality
assurance efforts and build mutual reliance in an integrated food safety system
• Utilize a diversity procurement strategy for goods and services related to this
agreement
Through these efforts, we will meet individual laboratory and broad-based training
needs around ISO/IEC 17025:2017 laboratory accreditation, laboratory procedures,
data transfer (to NCBI and FDA data systems), document control, quality management
systems, continuous improvement, sample collection, and risk assessment. We will plan
and host forums for LFFM food testing laboratories and GenomeTrakr laboratories. We
will foster collaborations with the Partnership for Food Protection around scientific and
data sharing goals. Measurement of success will be against stated metrics, refined in
consultation with the funding agency.
As the non-profit association representing state and local laboratories that conduct HAF
testing for over 50 years, APHL can efficiently advance the goals of this Cooperative
Agreement. Leveraging our experience will better position FDA to work in partnership
with state and local authorities to build an Integrated Food Safety System and achieve
national public health goals.

Public health relevance
Project Narrative The purpose of this proposal from the Association of Public Health Laboratories (APHL) is to support and enhance the capabilities of state human and animal food (HAF) testing laboratories that engage in surveillance and response activities associated with foodborne hazards, including foodborne outbreak investigations. APHL will build a competent HAF Laboratory workforce, plan and host conferences related to LFFM disciplines, the GenomeTrakr network, and NARMS, provide direct technical assistance to non-FDA funded HAF laboratories, maximize HAF laboratory participation in the GenomeTrakr network including development of the bioinformatics workforce, and promote information sharing between strategic partners. Leveraging our experience will better position FDA to work in partnership with state and local authorities to build an Integrated Food Safety System and achieve national public health goals.